An innovative label-free dual-nanopore TOF sensor for detection and identification of single molecules

TITLE: Biotechnology Resource Center of BioModular Multi-scale Systems (CBM2) for Precision Medicine
TR&D 2: An innovative label-free dual-nanopore TOF sensor for detection and identification of single molecules
Abstract
Nanofluidic devices offer promising and highly innovative approaches for analyzing single molecules and
obtaining biophysical information that cannot be realized using microfluidics due to scaling issues. The ability to
provide reliable, rapid, quantitative, and low-cost identification of single molecules will offer exciting new
opportunities for a broad range of biomedical applications. The goal of TR&D 2 of the Biotechnology Resource
Center of BioModular Multi-scale Systems (CBM2) for Precision Medicine is to produce an innovative label-free
nanofluidic sensor for not only detecting single molecules, but identifying them as well. The hypothesis behind
our nanosensor is, “individual molecules moving electrokinetically through a 2D nanotube will experience time-
of-flight (TOF) that are dependent upon their molecular identity.” We have demonstrated this concept in our
active P41 with baseline separations of fluorescently labeled deoxynucleotide, ribonucleotide monophosphates
and oligonucleotides via their time-of-flight (TOF) through a polymer-based nano-column. TR&D 2 aims to extend
the TOF differentiation of single molecules to a label-free approach. Label-free readout of the molecular-
dependent TOF is achieved using dual-nanopore TOF sensors, where two or more in-plane nanopores are
placed at either end of a nano-column, which is used for nanoscale electrophoresis. The molecular TOF
measured by the time delay between two consecutive current transient signals provides a signature to allow for
identification of single molecules. In the active P41 Center, preliminary data have demonstrated this capability.
This TR&D will develop the hardware and software required for high throughput label-free TOF sensing. High
rate manufacturing of the nanosensor with sub-5 nm in-plane nanopores will be achieved via NIL using the
manufacturing protocols that we developed in our active P41. This will be combined with the development of
data processing electronics and single-molecule identification algorithms based on machine learning to increase
identification accuracies. Technologies required to build multiple nanosensors on a single chip (>100 sensors
per chip) will be developed, which include large area molding tools, replication processes, reliable
electrical/fluidic connections, and electronics/software. This will allow for high throughput processing of single
molecules. As a demonstration of the technology developed in this TR&D, we will use the dual-nanopore TOF
sensor to assess epigenetic modifications of DNA. By integrating solid-state nano-reactors (TR&D 1) with
optimized dimensions of the in-plane nanopores and nano-columns, this sensor can be configured to provide
molecular information from unamplified targets (DNA, RNA, and proteins) with unprecedented identification
accuracies (>95%). This will transform single-molecule processing to allow servicing a broad biomedical
community for a wide range of applications.

Public health relevance
Narrative The Biotechnology Resource Center of BioModular Multi-scale Systems (CBM2) for Precision Medicine will produce an innovative label-free nanofluidic sensor with in-plane nanopores for not only detecting unamplified single molecules, but also identifying them via their molecular-dependent time-of-flight (TOF). The hardware and software required for high throughput label-free TOF sensing will be developed. By integrating solid-phase nanoscale reactors with the in-plane nanopores and nano-columns, this sensor can be configured to provide molecular information from unamplified targets (DNA, RNA, and proteins) with unprecedented identification accuracies (>95%).